A Computational Framework for Protein Identification and Quantification in Metaproteomics Using Data-Independent Acquisition

Summary Extensive efforts to characterize the human microbiome have tremendously increased the knowledge about the diversity of the microbiome and about its composition in health and in disease. Dysbiosis in human microbiota underlies the development of many diseases, such as obesity, diabetes, and inflammatory bowel disease. Metaproteomics based on mass spectrometry (MS) has become widely used in microbiome research for gaining insights into the functional states of microbial communities. Mass spectrometry with data-dependent acquisition (DDA) is the most common method of choice for identifying and quantifying microbial proteins in metaproteomics, but this technique is fundamentally limited in terms of reproducibility and comprehensiveness. Proteomics using data-independent acquisition (DIA) can, in theory, resolve the fundamental problems associated with the DDA method. However, the lack of bioinformatics tools still presents unresolved challenges in the context of DIA, and only few DIA applications on microbiome or host-microbe interactions have been reported. MS-based metaproteomics is a challenging measurement due to the high complexity with thousands of species at vastly different abundances. To obtain a comprehensive characterization of the functional state of microbial communities requires considering proteins not just from dominant microorganisms but also low-abundance microorganisms. This proposal addresses the need for identifying and quantifying proteins through the availability of a set of computational tools that use DIA data to identify and quantify peptides and their variants at the microbial strain level. The false peptide identifications are controlled by newly proposed methods for false discovery rate assessment at multiple granularities. The protein inference and quantification are optimized by linear programming models that contain information from genome/transcriptome sequencing data and metaproteome sample replicas. The improvement will increase the number of identified protein variants, especially those from the low-abundance microorganisms, which can help accurately characterize the functional composition in microbial communities and reveal the functional redundancy.

Public health relevance
Project Narrative Host-microbiome interactions have been shown to play essential roles in human health and diseases. The proposed project aims to develop computational tools for functional analysis of the microbiome, which are needed to better understand the intricate host-microbiome interactions. Given the essential roles of microbiota in maintaining the health of hosts, the success of this project will yield long-term benefits, such as the development of novel diagnostic and therapeutic strategies.